Molecular Mechanism and Regulation of Asynchronous Release

Project Summary/Abstract
Neurotransmitter release is influenced by drugs, and certain mental disorders such as depression, but the details are
unclear. It is mediated by the SNARE complex, complexin (Cpx), synaptotagmin (Syt), and other proteins. Asynchronous
release is a mode of neurotransmitter release. It has received increasing attention as it may generate or compensate
abnormal neural activities, and play critical role in pre-synaptic plasticity. While most neuronal communication relies
upon synchronous release triggered by the Ca2+ sensors Syt1, 2 and 9 (collectively called “fast Syts”). Asynchronous
release has a longer, variable delay after an action potential or series of action potentials, and it is mediated by the Ca2+
sensor Syt7. Fast Syts and Syt7 share a similar domain structure and a high degree of homology in their Ca2+-binding C2A
and C2B domains. Recently I have identified the "primary" SNARE-Syt1 interface between Syt1 C2B domain and the
SNARE complex, revealing the "primary" interface is specific for synchronous release. In contrast, Syt7 does not form a
similar "primary" interface. These results raise the following questions: 1) how does Syt7's cooperate with SNAREs and
Cpx to trigger "delayed" asynchronous release; 2) what is the difference between fast Syts and Syt7 that gives rise to the
different modes of neurotransmitter release; 3) how is asynchronous release regulated by Syts and Ca2+. The overall goal
of this proposal is the elucidation of the molecular mechanism and regulation of asynchronous release. The proposed
study will examine how Syt7 mediates asynchronous release in cultured cortical neurons and brain slices from Syt1/7
double knockout mice with re-introduction of mutates designed based on sequence analysis and a newly solved crystal
structure of SNARE-Cpx-Syt1 complex. Finally, I will reveal the interaction among Syt1/7, Cpx, SNARE complex and
membrane, and investigate the regulation of asynchronous release by Syt1, Syt7 and Ca2+. Combined with my work on
synchronous release, such results are expected to provide a better understanding of the roles of neurotransmitter release in
neural activity and mental disorders, may lead to new therapeutics for the prevention and treatment of a variety of mental
disorders. In addition, the results are also expected to vertically advance the understanding of pre-synaptic plasticity
which is believed to be related to memory, learning, and behavior, as well as fundamentally advance the field of
neuroscience. My long-term career goal is to lead a world-class laboratory in the forefront of synaptic physiology. I intend
to use techniques in structural biology, single molecule spectroscopy and imaging, as well as key techniques in
neuroscience as investigation tools. To complement my knowledge of structural biology acquired during my PhD, I will
carry out the mentored phase of this Award as a postdoctoral Research Fellow in the laboratories of Drs. Axel Brunger
and Thomas Südhof. I have designed an ambitious research career development plan to achieve my immediate goals for
the mentored period: 1) expand my advanced scientific and technical knowledge, and 2) prepare my transition to
independence. Under the mentorship of Drs. Brunger and Südhof, I will follow a structured training program to enhance
my professional abilities to establish and run my own laboratory. Stanford Medical School will provide me with ideal
environment to fully benefit from this Award and become a successful independent scientist.

Public health relevance
Project Narrative The proposed study will provide critical information regarding our understanding of asynchronous release, a longer and variable delayed neurotransmitter release at synapses. Abnormal neurotransmission underlie mental illnesses such as schizophrenia or depression, especially asynchronous release plays an important role in generating or compensating for abnormal neural activities. Elucidating the molecular mechanisms and regulation of asynchronous release will greatly advance understanding of synaptic plasticity and neural circuit, provide a better understanding of the roles of neurotransmitter release in neural activity and mental disorders and may lead to new targets and treatments for mental illnesses.